IND-enabling studies for a potent and efficient neuroprotective drug

Project Summary/Abstract
Global Cerebral Ischemia (GCI) afflicts over 700,000 Americans each year and often results in permanent
cognitive impairment or death. Here, we will complete IND-enabling studies for a therapeutic strategy for GCI.
Our optimized peptide inhibitor of CaMKII, tatCN19o, shows effective and potent neuroprotection in animal
models of GCI that closely mimic the most relevant human conditions: cardiopulmonary resuscitation (CPR) after
cardiac arrest in mice or after ventricular fibrillation in pigs. When our CaMKII inhibitors were injected i.v. at a
clinically relevant timepoint after GCI, they provided dramatic improvement over therapeutic hypothermia alone
(the current standard of care); after combination with therapeutic hypothermia, only residual and barely
detectable neuronal cell death was seen. Neuroprotection manifested on the anatomical, synaptic, and
behavioral level. Target validation has been done using mutant mice with impaired CaMKII signaling. Target
engagement has been characterized by biochemical and structural studies. This current lead compound has
been optimized for potency (ki of 0.1 nM) and selectivity (>100,000x compared to the most closely related
kinases). Intellectual property protection for tatCN19o is in place. The tatCN19o peptide is a tight-binding active
kinase inhibitor that only engages the CaMKII fraction that remains hyperactivated after ischemic insult. These
features enable optimal efficacy at an extremely low dose (0.01 mg/kg i.v.). TatCN19o is a cell- and blood-brain-
barrier –penetrating 30mer peptide that is readily soluble in water or saline and highly stable in lyophilized or
solubilized formulation (to be further characterized here). Current data suggest a favorable safety profile (also to
be further characterized here), including lack effects on memory. These characteristics enable straightforward
preparation of an injectable for clinical use in humans. Notably, tatCN19o inhibits rodent and human CaMKII
equally well. Phase I of this project achieved the proposed key preclinical milestones for tatCN19o, including:
characterize binding kinetics of dissociation from target, establish a quantitative method for detection in plasma,
and evaluate pharmacokinetics in safety species. To enable testing in humans, this SBIR project will conduct
studies required for a successful IND application, including (1) an in vivo extension of our in vitro characterization
from Phase I, (2) formulation development, (3) pivotal safety studies, and (4) regulatory document preparation.
The results of this proposal will serve as critical components of an IND application to the FDA, in preparation for
a Phase I clinical trial and ultimately commercialization. Our Pre-IND meeting is planned for the end of year 1.
The clinical/market potential for tatCN19o as a GCI therapeutic is detailed in the Commercialization Plan.

Public health relevance
PROJECT NARRATIVE Global cerebral ischemia (GCI) occurs not only during drowning and suffocation, but also during cardiac arrest. This results in neuronal cell death, especially in brain areas important for learning and memory, which causes many GCI patients to experience long-lasting cognitive impairments. This proposal will work towards approval of first-in-human clinical trials of a compound (tatCN19o) that can protect neurons from cell death even when administered after GCI has already occurred.